Reelin and Receptor Splicing in Alzheimer's Disease

Reelin signaling enhances hippocampal synaptic plasticity and increasing evidence
suggests Reelin serves a neuroprotective role in Alzheimer’s disease (AD). Reelin delays AD hallmarks
including amyloid plaque formation, tau hyperphosphorylation, and cognitive deficits, contributing to remarkable
resilience against AD. Reelin’s ability to enhance synaptic plasticity is dependent on its obligate
APOER2/VLDLR receptors that are prone to high degree of alternative splicing. We uncovered a diverse range
of human full-length APOER2 splice transcripts in postmortem AD brains and age-matched controls. Most of
the splicing events occur in functionally important domains such as the ligand-binding domains where Reelin
binds suggesting variation in ligand-receptor interactions and functional consequences related to Reelin
signaling; however, this has not been explored. The project includes three aims. Aim 1 seeks to determine if
alternative splicing of APOER2 and VLDLR, the obligate receptors of Reelin, impacts AD risk. Aim 2 will assess
the functional consequences of receptor splice variants on Reelin binding and signaling, proposing that specific
interactions may either protect against or increase AD risk. Finally, Aim 3 will explore the mechanism of Reelin's
resilience in AD-associated tau pathology, utilizing a CRISPR activation strategy to increase endogenous Reelin
expression with the goal of reversing tau pathology-related deficits. This project, poised to deliver high-impact
insights of resilient AD genes and promising therapeutics in the AD field.

Public health relevance
Reelin signaling plays a pivotal role in memory formation and serves as a protective pathway against Alzheimer’s disease (AD). A crucial aspect of Reelin’s effectiveness in enhancing synaptic plasticity hinges on its cognate receptors, APOER2 and VLDLR, which are characterized by a high degree of alternative splicing. This proposal aims to understand the mechanisms underlying the impact of receptor splicing on ligand-receptor interactions and signaling, and how these dynamics affect neuronal function and susceptibility to AD.